CORE 5: DISSEMINATION

The user community for SIMTK is large. The DBPs during our first five years demonstrate the breadth of problems for which physics-based modeling and simulation are critical. The RNA folding and protein folding/misfolding DBPs included structural biologists, physical chemists, physicists, molecular biologists, physicians and biochemists. The myosin dynamics DBP included biochemists, biomechanical engineers, geneticists, chemists, biophysicists, and structural biologists. The neuromuscular dynamics DBP included orthopedic surgeons, biomechanical engineers, neurologists, and physical therapists. The cardiovascular fluid dynamics DBP included vascular surgeons, cardiologists, vascular biologists, and bioengineers. The three new DBPs, summarized under Core 2 similarly engage a broad spectrum of scientists, including structural biologists, neurologists, electrical engineers, biochemists, pharmaceutical chemists, physicians, computer scientists and biomedical engineers. These users will again provide appropriate pull on SIMTK to ensure that it has relevant and useful capabilities. We have disseminated the fruits of Simbios research and development through traditional publications (over 150 papers), presentations at conferences, workshops, and via the materials on our simtk.org website.